Corticosubthalamic Plasticity in the Parkinsonian State

ABST RACT
In current schemes of the pathophysiology of Parkinson’s disease (PD), neuronal activity changes in the sen-
sorimotor region of the subthalamic nucleus (STN) play a central role in the development of parkinsonism. Until
recently, the changes in STN activity were thought to result solely from reduced inhibition from the external
globus pallidus (GPe). However, recent findings from animal models of advanced parkinsonism have suggested
that a profound loss of glutamatergic cortico-subthalamic terminals and an increased strength of GABAergic
pallidosubthalamic synapses may contribute to activity changes in the STN and to the development of parkin-
sonism. Our preliminary data demonstrate that a loss of cortico-subthalamic terminals is also present in the
sensorimotor STN territory of people with advanced PD. It remains unclear, however, how these anatomical and
physiologic changes relate to the degree of nigrostriatal dopamine loss and to the expression of parkinsonism.
Further, it is unknown if these changes also affect non-motor regions of the STN, perhaps contributing to cogni-
tive or affective PD symptoms. We will examine these issues with neuropathological and electrophysiological
studies in monkeys with different degrees of MPTP-induced dopamine loss (Aim 1), and with longitudinal 7T
ultra-high field MRI studies in people with early PD (Aim 2). In Aim 1, we will record responses of STN neurons
to optogenetic activation of cortical and pallidal inputs in monkeys that remained either asymptomatic after ex-
posure to small dose of the dopamine-depleting neurotoxin MPTP or became parkinsonian after exposure to
(larger doses of) MPTP. We will also assess changes in local field potentials (LFPs) and abnormal spiking
activity in STN, and in the coherence between STN LFPs and motor cortical electrocorticograms. In postmortem
studies of the same animals, we will use high resolution microscopic immunohistochemical studies and 3D-EM
reconstructions to assess whether the number, localization, and morphology of glutamatergic and GABAergic
synapses in the STN changes as a function of dopamine loss. We will also compare the number of cortico-
subthalamic terminals and examine changes in GABAergic markers in STN tissue from patients with PD and
age-matched controls. In Aim 2, we will use state-of-the-art diffusion and resting state functional MRI to test
whether humans with early stage PD exhibit significant changes in the volume and microstructural organization
of the STN and its cortical and pallidal afferents, and determine if these changes are related to the expression
and progression of motor and non-motor impairments. The same patients will be studied at enrollment and 30
months later to examine changes in the MRI measures. The results of this project will increase our understanding
of the temporal evolution of parkinsonism-associated plastic changes in the STN, and determine their potential
relationships to the development and severity of motor and non-motor signs and symptoms of the disease. These
studies may lead to novel interventions to control or prevent abnormal firing patterns in STN and may contribute
to the development of imaging biomarkers to identify early stages of PD and predictors of disease progression.

Public health relevance
PROJECT NARRATIVE Recent studies have suggested that imbalanced activity between synaptic excitation and inhibition in the subthalamic nucleus contribute to parkinsonian motor signs in animal models of advanced parkinsonism. Using state-of-the-art physiologic and anatomical methods in monkeys, we now propose to examine how the observed synaptic changes relate to the degree of dopamine loss and the severity of parkinsonism. Further, we plan to conduct a longitudinal ultra-high-field MRI study in patients with Parkinson's disease to study the extent to which changes in the connectivity of the subthalamic nucleus accompany the development of motor and non-motor signs of the disease in humans.